Path C The FDA's Cooperative Agreement Program for States and Territories to Implement a National Produce Safety Program (U2F) Clinical Trials Not Allowed

KDA Produce Safety Program
Project Summary/Abstract
In 2022, the KDA Produce Safety Program assumed fully state authority for Produce
Safety in Kentucky via the passage of a State Produce Safety Statute/Regulation.
Under the 2021-2026 Period of Performance, KDA intends to shift its efforts from
building a state program to that of full implementation of FDA’s national Produce Safety
Program. During the next 5-year Period of Performance, KDA aims to utilize this robust
regulatory foundation, along with fully executed, foundational program SOPs to fully
execute a robust Farm Inventory, Education/Outreach,
Inspection/Compliance/Enforcement, and Produce-Related Event Response foundation
towards the specific aim of assisting federal/state partners and Kentucky produce
growers in achieving Standards for the Growing, Harvesting, Packing, and Holding of
Produce for Human Consumption (21 CFR Part 112).
The overall health relatedness of this project is that of consumer and public health
protection by implementing specific goals/objectives in the Project Plan aimed at
minimizing the risk of serious adverse health consequences or death from consumption
of contaminated produce through the application of science-based minimum standards
for the safe growing, harvesting, packing, and holding of produce raw agricultural
commodities grown for human consumption. This cooperative agreement is for full
program execution directed towards grower education, technical assistance,
development of a verified inventory of covered farms and conducting prioritized
inspections of farms covered by the Produce Safety Rule. KDA and its sub-awardees
will continue to conduct education, outreach, and identification of covered farms. KDA’s
long-term objectives, specific aims, and key focus during 2021-2026 Produce Safety
CAP Grant Period of Performance seek to ensure that robust Administrative, Farm
Inventory, Regulatory Program Foundation, Education/Outreach, and
Inspection/Compliance/Enforcement systems are in place and fully executed in order to
advance Federal/State efforts for a nationally integrated food safety system (IFSS),
enhance produce safety in the Commonwealth and abroad, and achieve high rates of
compliance with FDA’s Produce Safety Rule and the state statute/regulation.

Public health relevance
KDA Produce Safety Program Project Narrative The relevance of this project to public health is to minimize the risk of serious adverse health consequences or death from consumption of contaminated produce through the application of science-based minimum standards for the safe growing, harvesting, packing, and holding of produce raw agricultural commodities grown for human consumption as contained in 21 CFR Part 112. This project will allow KDA to continue to build a robust, verified farm inventory which will be shared with our federal partners. Through both the application of a robust Education/Outreach and Inspection/Compliance/Enforcement program, as promulgated in Kentucky’s Produce Safety Statute (KRS 260.765 to 260.772.) and Produce Safety Administrative Regulation (302 KAR 60:010), the KDA Produce Safety Program will ensure that both covered and exempt growers of covered produce understand and, where applicable, apply the regulatory mandates and produce safety best practices to reduce produce- related illnesses and ensure a safe, wholesome food supply for the Commonwealth and abroad.